SDSU ADAR Program

San Diego State University (SDSU) is applying for a competitive renewal to continue its National
Institute of Aging MSTEM: Advancing Diversity in Aging Research (ADAR) Undergraduate
Education program to increase the number of highly qualified underrepresented racial and
ethnic minority, disabled, and disadvantaged students who enter Ph.D. programs focused on
aging research. Consistent with the NIA program announcement, the SDSU ADAR program
provides: 1) 3 years of structured research experiences with outstanding mentors; 2) tailored
learning opportunities; 3) an emphasis on the relevance of aging and of the science of aging to
the scholars' lives; and 4) activities to engage students to develop a cadre of graduates who will
go on to research careers that will diversify the research workforce on aging. The SDSU ADAR
program benefits from a partnership between SDSU and the University of California, San Diego
(UCSD). The partnership has a long history of highly successful joint doctoral programs, training
grants, and research collaborations. In addition, partnering with UCSD provides ADAR scholars
with research opportunities available through its medical school. Another unique feature of the
SDSU ADAR program is an extramural research experience at leading research institutions that
all scholars complete during their second summer. This transformative experience provides the
scholars many benefits, including becoming part of a research group at what often is the
scholar's first extended journey away from home. The first cohort of SDSU ADAR scholars
graduated in May of 2017. All graduating scholars entered excellent Ph.D. programs in the field
of aging. SDSU has a wealth of eligible and motivated students. The SDSU ADAR PI has more
than 20 years of experience in developing and leading successful training programs, and the
program benefits from dedicated and nationally recognized research mentors who have made
major contributions to the field of aging research. With these attributes and a training program
that has successfully placed ADAR scholars into top-notch Ph.D. programs, the SDSU ADAR
program is well positioned to meet the goals of the National Institute of Aging MSTEM:
Advancing Diversity in Aging Research (ADAR) Undergraduate Education program.

Public health relevance
San Diego State University (SDSU) is applying for a competitive renewal to continue its National Institute of Aging MSTEM: Advancing Diversity in Aging Research (ADAR) Undergraduate program to increase the number of highly qualified underrepresented racial and ethnic minority, disabled, and disadvantaged students who enter Ph.D. programs focused on aging research. The first cohort of SDSU ADAR scholars graduated and entered excellent Ph.D. programs in the field of aging.